The Biochemistry of Clock Function in Fluctuating Environments

Project Summary
Circadian rhythms are daily oscillations in behavior with a nearly 24-hour period that are generated by
an internal biological clock. Across many organisms, health and fitness are impaired when the circadian
clock does not appropriately synchronize with the daily cycles in the external environment. It is thus
critical to understand how clocks respond to challenging fluctuating environments with intermittent or
irregular inputs that are typical of modern life. This problem is conceptually challenging because
circadian clocks are complex systems. In general, there is a core oscillator consisting of biochemical
circuitry that generates a rhythmic daily signal, and the timing of this rhythm can be adjusted by input
signals that communicate information about the environment to the oscillator. However, this oscillator
is also embedded in the rest of cellular physiology, and so its response to a changing environment is
likely contingent on the status of metabolism and other signaling pathways. We are using the bacterial
model organism Synechococcus elongatus to crack the problem of clock-environment interaction
because this organism has the remarkable feature that the core oscillator can be reconstituted in vitro
using purified proteins. We will thus use a reductionistic approach to build up to an integrated
mathematical model of clock function in the intact cell when subject to environmental fluctuations. In
Aim 1, we will study the purified test tube oscillator, collecting a large data set of kinetic measurements
on the core clock proteins at various temperatures, metabolite concentrations, and protein
stoichiometries. Using advanced statistical approaches, we will then constrain a model of elementary
reactions to uncover how temperature compensation, metabolic sensing, and entrainment function in
the core oscillator. In Aim 2, we will study how the clock shifts in response to environmental fluctuations
in the living cell. Here we will use a novel assay to isolate the history-dependence of clock sensitivity
that is absent from the core oscillator. We will then use a genetic analysis to find the key pathways
used to modulate clock sensitivity in vivo. These data will then be incorporated into a expanded
mathematical model that describes the function of the clock in vivo when environmental conditions
fluctuate. In Aim 3, we will develop a deep mutagenic scanning approach, to find the clock phenotype
and competitive growth defects of 10,000s of point mutations in the clock genes simultaneously. This
will not only allow us to discover critical interaction sites on the clock proteins, but also to obtain a
comprehensive list of period mutants and mutants that disrupt temperature compensation. Because
this assay is based on the transcriptional feedback loops ubiquitous in circadian clocks, it can be
generally applied to other clock systems as well.

Public health relevance
Project Narrative Many organisms, including humans, have internal biological clocks that synchronize behavioral rhythms with the 24-hour rhythms in the environment, but when the external environment is unpredictable, as in jet lag or shift work, the consequences include impaired health, metabolic disruption, and decreased lifespan. It is not known how biological clocks maintain the correct time in potentially disruptive conditions nor precisely why metabolism suffers when rhythms malfunction. We are studying bacteria that have the simplest known circadian clock in order to answer these questions and pinpoint how biological clocks respond to changing environments.